Device-Agnostic Hypoxia Detection Software for Overdose Prediction and Positive Reversal Monitoring

ABSTRACT / PROJECT SUMMARY
Despite the availability of naloxone, opioid overdoses claim 84,181 lives annually in the U.S., with an
additional hidden toll of non-fatal opioid overdoses (NFOO) leading to hypoxia-induced brain injuries.
Opioid-induced respiratory depression (OIRD) remains the primary cause of hypoxia-related brain injuries,
which can lead to long-term neurological impairments such as encephalopathy, cognitive deﬁcits, and motor
dysfunction. These injuries begin within four minutes of hypoxia onset, while EMS response times average
over nine minutes. Furthermore, ~52% of overdoses occur when the individual is alone, and even in the
presence of bystanders, 27% fail to recognize the diﬀerence between opioid use and a potentially fatal
overdose.
To address this, DOVE combines an innovative shoulder-wearable sensor with device-agnostic software to
predict fatal overdoses and facilitate eﬀective reversal interventions. DOVE integrates advanced algorithms
that analyze SpO2 levels, respiratory rates, and motion patterns, delivering real-time verbal feedback akin to
an automated external deﬁbrillator (AED). This guidance enables responders—whether harm reduction
volunteers, EMS, or law enforcement—to administer tailored interventions, such as naloxone redosing or
bag-valve-mask (BVM) ventilation. Importantly, DOVE addresses challenges posed by novel substances like
xylazine, which impede respiratory recovery and render naloxone insuﬃcient. BVM, a preferred alternative
among 105 harm reduction stakeholders interviewed during NIH I-Corps, oﬀers a more humane and eﬀective
means of restoring oxygenation in complex overdose scenarios.
The project encompasses a one-year Phase I to build on our I-Corps participation to validate
commercialization potential. Phase I focuses on developing device-agnostic software for hypoxia monitoring
and validating biomarkers for overdose prediction and reversal. This includes stakeholder feedback, feasibility
analysis, and FDA guidance, laying the groundwork for Phase II clinical trials.

Public health relevance
NARRATIVE DOVE aims to address the critical gap in timely detection and monitoring of 214,000 annual Non-Fatal Opioid Overdose (NFOO) events which can lead to long-term neurological impairments by providing a device-agnostic software solution designed to predict fatal overdoses and guide responders in overdose reversal interventions. DOVE oﬀers overdose prediction 4 minutes in advance and real-time verbal feedback, akin to an AED, guiding users through appropriate interventions, including naloxone redosing or bag-valve-mask (BVM) ventilation. This is especially critical in the context of adulterants like xylazine, a sedative increasingly found in opioid mixtures, which complicates overdose responses. Supported by foundational work, including real-world OUD and sleep apneic patient data captured by DOVE, and complemented with open-source resources like OpenOximetry, DOVE has robust validation mechanisms for testing its ability to function across diverse devices, ensuring its potential for scalability and adaptability across various environments.